MIAMI BREAST CANCER EDUCATION SUMMIT

This proposal is for the development, implementation, and evaluation of a Breast Cancer Education Summit, at the Sylvester Comprehensive Cancer Center in Miami, Florida. The Summit will target 40 corporations, community agencies or organizations who serve either of two hard-to-reach populations: Hispanics and older women. The content will cover state-of-the-art information on breast cancer and early detection, as well as examples of "on-site" early breast cancer detection and education programs that have been successfully developed by organizations or corporations. During the Summit, attendees will develop their own plans and timetables for implementing or enhancing an on-site early breast cancer detection and/or education program, assisted by research oncology nurse facilitators. Analyses will include both process and outcome evaluations.